APPLES-tele Diversity Supplement

ABSTRACT
Through supplemental work on the parent R01, this project aims to provide research training,
mentorship, and career development opportunities to build the early career of an emerging
Latina clinician-researcher and increase monolingual Spanish speaking Latinx community
participation in clinical trials for neurodevelopmental disorders. Engaging underserved
communities in clinical trials is challenging. Even when rehabilitation research is stakeholder-
informed from design to enactment, it does not always allow minority groups to access certain
studies. People of Latin American origins in the United States (US) are growing minority group,
who are at high-risk for marginalization in the healthcare system and in research. For Latinx
children and families with CP, marginalization can occur due to the intersection of socio-
demographic obstacles, language, and culture. As a result, they may experience poor health
outcomes that compound over time and further impede participation in clinical research
evaluating the acceptability and effectiveness of interventions for CP. Yet, if this challenge can
be addressed, it would significantly improve the generalizability of interventions for CP that
engage parents as active participants in research and healthcare managers for their children.
Towards this end, the current supplement evaluates the hypothesis that culturally appropriate
adaptations of motor and parenting interventions from the parent R01 will increase enrollment of
a geographically representative sample of US Latinx children with CP in the parent R01. Two
specific aims are proposed. Aim 1: Two-year enrollment of a geographically representative
sample of Latinx children with CP in the parent R01 will increase when culturally appropriate
translations and adaptation of materials are used and improve understanding of caregiver
perceptions surrounding early CP diagnosis. Aim 2: The effect of each intervention when
delivered in Spanish (appropriately adapted for cultural norms) to Latinx families will not differ
relative to English in English-speaking families matched for social determinants of health. The
data collected in the proposed supplement will improve access of US Latinx families to clinical
research interventions and inform approaches to enhance research participation in
neurodevelopmental disorder related clinical trials. The proposed supplement will also provide
insight into caregiver perceptions of early diagnosis that may inform clinical care.

Public health relevance
PROJECT NARRATIVE The purpose of this supplement is to build the early career of an emerging Latina clinician- researcher. The project’s purpose will be accomplished through supplemental work on an existing funded grant. The supplement aims to increase participation of the United States (US) Latinx community in clinical trials for neurodevelopmental disorders. The proposed project has broad public health relevance because it will improve access of US Latinx families to clinical research interventions. Data from this project will inform approaches to enhance research participation in neurodevelopmental disorder related clinical trials among the Latinx community, which is well aligned with the NICHD’s mission.